Gut microbiota-derived signaling in liver carcinogenesis and cancer treatment

PROJECT ABSTRACT
Hepatocellular carcinoma (HCC) is a deadly disease with limited treatment options. Therefore, there is an
urgent need to develop alternative treatments for liver cancer, which is the primary goal of this application
under the existing research program (1R01 CA222490). An effective cancer treatment strategy should target
the pathways by which cancer arises in the first place. Emerging evidence also reveals that gut microbiota-
derived signaling is not only implicated in colon cancer but also affects hepatic inflammation and liver
carcinogenesis. Thus, to develop targeted strategies for liver cancer treatment, it is important to uncover the
mechanism of gut-derived signaling in the liver. The Research Specialist (Dr. Ying Hu) and Unit Director (Dr.
Yu-Jui Yvonne Wan) have worked together for the past 8 years, starting in 2011, and have generated 11 peer-
reviewed publications in cancer research. Dr. Wan's research programs have been sponsored by a long-term,
continuously funded R01 grant, NCI R01 CA053596 (1991-2016), and a cooperative U grant NCI U01
CA179582 (2014-2019, lead PI), NCI R01 CA222490 (2018-2023), and NIDDK R01 DK092100 (2011-2017).
Dr. Hu has participated in all of these above-mentioned projects and has a thorough understanding of how Dr.
Wan's cancer research program evolved. Dr. Hu has unique expertise in the gut-liver axis as well as in
orthotopic liver and colon cancer animal models. She has conducted extensive research using both liver and
colon cancer cells and mouse models to study the pathways controlled by natural compounds present in the
gut and liver, including bile acids (BAs), retinoic acid (RA), and short-chain fatty acids (SCFAs). Our research
program (1R01 CA222490) focuses on these natural chemicals, which are directly or indirectly produced by gut
microbes and are able to induce the tumor suppressor miR-22 in the liver and colon. Thus, miR-22 and its
inducers can not only induce cancer cell apoptosis and arrest, but also provide a preventive means to stop
cancer reoccurrence, leading to an effective treatment strategy. The applicant, Ying Hu, has worked closely
with Dr. Wan in developing plans to achieve the following goals: Aim 1 studies the mechanism by which miR-
22 has an anti-cancer effect by studying the downstream targets of miR-22. Aim 2 examines the role of miR-22
in liver cancer treatment using orthotopic liver cancer mouse models. Aim 3 analyzes the role of miR-22
inducers in liver cancer treatment. Successful completion of the proposed studies will lead to novel strategies
to treat liver cancer as well as colon cancer via miR-22 targeted pathways. The funds freed-up due to funding
of the current application will allow us to develop other collaborative programs that will lead to submission of an
SBIR grant application to advance Dr. Hu's career goals. Dr. Wan is the primary support Unit Director who will
continue to work with Dr. Hu to plan, direct, and execute the proposed research.

Public health relevance
PROJECT NARRATIVE The funded NCI grant (R01 CA222490) titled “Liver Cancer Therapy by miR-22 and Its Inducers” studies the effect of gut-derived signaling through miR-22 induction to combat liver cancer. The current application will provide Dr. Ying Hu, the Research Specialist, a protected and stable position to facilitate the completion of the NCI-funded grant. The outcome of this study can benefit both prevention and treatment of liver as well as colon cancer because the targeted pathway is responsible for carcinogenesis in both organs.